X-Ray Crylatllography

PROJECT SUMMARY (See instructions): The X-ray Crystallography and Molecular Characterization Facility provides access to state-of-the-art x-ray crystallography instrumentation and computational resources, and a wide variety of biophysical approaches lo understanding important molecular interactions. The Facility maintains the equipment and technical expertise to carry out all stages of macromolecular structure determination, and to measure molecular binding parameters such as association and dissociation rates as well as secondary and tertiary structure of biological samples. This facility was used by 6 KCC members.

Public health relevance
RELEVANCE (See instructions): The X-ray Crystallography and Molecular Interactions Facility provides KCC members access to state-of-the art instrumentation and expert advice that will help them develop a molecular level understanding of key biological molecules that contribute to the onset and progression of cancer.